Identification of NNMT as a New Target to Treat Triple-negative Breast Cancer

Summary
Triple-negative breast cancer (TNBC) is the most aggressive disease noted for the development of recurrence,
distant metastases and short survival times, particularly and tragically in young women. Mounting evidences
indicate that TNBC cells underwent a metabolic rewiring to scavenge the upsurge of reactive oxygen species
(ROS) encountered during metastasis in order to survive and outspread. The overarching goal of this proposal
to identify the metabolic dysregulation and signaling pathways governing metastasis in TNBC, and to develop
novel intervention to prevent this deadly disease. Recently, we found that a robust induction of nicotinamide N-
methyltransferase (NNMT) is concomitant with ROS upsurge when TNBC cells detached from matrix and grown
in anchorage-independent manner. NNMT-KO inhibits anchorage-independent growth in vitro, and suppresses
tumor growth and metastasis in vivo. Further mechanistic analyses indicate that NNMT-KO induces soaring ROS
and promotes ferroptosis by decreasing the levels of NAD(P)+ and glutathione (GSH). We hypothesize that
NNMT is a salient molecule to promote NAM uptake and NAD(P)+ synthesis in TNBC cells under anchorage-
independent growth, thereby alleviating rising ROS and protecting them from ferroptosis. Thus, NNMT
represents an appealing therapeutic target to inhibit TNBC survival and metastasis. In line with this idea, our
newly developed NNMT specific bisubstrate inhibitor presents a proof-of-concept as they potently suppressed
TNBC growth both in vitro and in vivo. Guided by strong preliminary data, we will test this hypothesis by pursuing
three specific aims: 1) to define how NNMT promotes anchorage-independent growth and protects ferroptosis
in TNBC; 2) to evaluate the potency, specificity, and mechanism of NNMT bisubstrate inhibitor in TNBC; and 3)
to determine NNMT’s function and explore therapeutic potential of NNMT inhibitor in pre-clinical mouse models.
We will utilize a wide variety of innovative, complementary and systematic methods to vigorously validate the
central hypothesis and achieve the goals of this study. This is multiple PI project combines the Zhou laboratory’s
strength in TNBC research with the Huang laboratory’s expertise in drug discovery and medicinal chemistry. Our
proposal is innovative and significant, because NNMT represents the Achilles heel of TNBC cells; targeting this
key molecule with specific inhibitor offers an immense potential for treating metastatic TNBC in the near future.

Public health relevance
Project Narrative Nicotinamide N-methyltransferase (NNMT), a prime enzyme that promotes the synthesis of cellular antioxidants, is essential to scavenge soaring ROS and protect TNBC cells from ferroptosis under anchorage-independent growth. This study will not only delineate the function and regulation of NNMT in TNBC but also determine the therapeutic efficacy of specific NNMT bisubstrate inhibitor for treating this disease in preclinical models.